Targeting SMARCA2 to overcome resistance of SMARCA4-mutant lung cancer to KRAS G12C inhibitors

Project summary
Lung cancer is a devastating disease that remains the top cause of cancer mortality. Despite
improvements in targeted therapies against oncogenic kinases and immunotherapies for select patients, the
majority of patients with lung cancer still lack effective therapeutics, underscoring the dire need for additional
treatment approaches. Recent discovery of KRASG12C inhibitors (KRASG12Ci) has generated tremendous
excitement and hope. Unfortunately, the duration of response to KRASG12Ci is very short with progression free
survival of only 6-7 months due to primary and adaptive resistance. Further, a recent clinical observation showed
that co-mutations in the tumor suppressor gene SMARCA4 predict even poorer response to KRASG12Ci, further
increasing the urgency to understand and overcome resistance in this context. We have recently corroborated
these clinical observations by various experimental approaches. As SMARCA2 is a known synthetic lethal
genetic interaction partner to SMARCA4, we sought to study whether targeting SMARCA2 is a possible strategy
to overcome resistance of SMARCA4 and KRAS co-mutant cells to KRASG12Ci. To this end, we have developed
small molecules that degrade SMARCA2 based on PROTAC (proteolysis targeting chimera) technology. Our
data indicates that SMARCA2 PROTACs, including our lead molecule YD23, induce robust SMARCA2
degradation, show promising combination effect with KRASG12Ci and are excellent chemical tools to determine
the therapeutic potential of SMARCA2 targeting.
In this proposal we first aim to investigate the mechanism of resistance of SMARCA4 mutant lung cancer
to KRASG12Ci. We intend to utilize several orthogonal, genetically well-defined model systems and perform in
depth molecular characterizations including unbiased transcriptomic, chromatin accessibility and SMARCA2/4
CUT&RUN to identify direct targets of SMARCA2/4 that are modulated by sotorasib, a prototypical KRASG12Ci.
We also intend to experimentally develop cell lines resistant to the combination of YD23 and sotorasib that should
help in understanding potential mechanisms of drug resistance that are expected in the future if used in patients.
To aid our understanding of potential side effects of combination of YD23 and sotorasib, we aim to perform
tolerability studies in mice. Importantly, we will determine the anti-tumor efficacy of YD23 and sotorasib using
established lung cancer xenografts and novel PDX models. Finally, we will determine gene expression changes
within tumors upon YD23, sotorasib as single agent or in combination to elucidate the molecular alterations
underlying the in vivo biological effects of our novel combination strategy.
In conclusion, these experiments are expected to elaborate the mechanism of resistance of SMARCA4
mutant lung cancer to KRASG12Ci and determine the potential utility of SMARCA2 PROTACs to overcome this
resistance. Finally, as KRAS inhibitors are rapidly evolving beyond G12C into other genotypes, our work could
have broader ramifications against multiple other cancer types.

Public health relevance
Project narrative While recent treatments to inhibit KRAS, a common cancer driver, have generated tremendous excitement and hope, not all patients respond to the treatment or stop responding quickly especially when they have mutation in a gene called SMARCA4. We have developed drug-like molecules that induce the destruction of SMARCA2, a protein that is required for growth of cancer cells with a mutation in SMARCA4 by utilizing a new technology that sends cancer-driving proteins to the cell’s waste disposal system. In this proposal, we aim to perform in depth biological studies to better understand resistance of SMARCA4 mutant cancers to KRAS inhibitors and attempt to overcome this resistance by using our novel drug-like molecules.